IMMUNOHISTOCHEMISTRY AND IMAGING CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This Core focuses on identifying the nature of cells after marrow cell transplantation. Donor cells and their specific lineages are ascertained and colocalized by high resolution microscopy and immunofluroescence. Donor cells are tracked in tissue sections or cell suspensions by expression of GFP, beta-galactosidase or the presence of male DNA. The lineage of identified donor cells are ascertained by standard morphology, geographical location and immunohistochemistry. Colocalization of donor and lineage markers are confirmed using fluorescent microscopy.